STUDY OF AMITRIPTYLINE AND MEXILETINE FOR PAINFUL NEUROPATHY IN HIV

The objective of this study is to evaluate the effectiveness of amitriptyline and mexiletine for relieving pain in patients with HIV- related painful neuropathy. The study is a three arm parallel group, placebo controlled clinical trial, with subjects randomly assigned to receive either amitriptyline, mexiletine, or active placebo.